Metabolomics a Novel Tool for Investigating the Pathogenesis of Age-related Macular Degeneration

PROJECT SUMMARY:
Age-related macular degeneration (AMD) is the leading cause of blindness in the elderly.1 Currently, there are
no treatments for its early and intermediate forms and there is a lack of reliable biomarkers to predict risk of
disease progression. Therefore, there is a great unmet need for better understanding the mechanisms of AMD
and its wide phenotypic variability. The metabolome is downstream of the genome and is simultaneously
impacted by a wide range of environmental exposures thus being considered a close representation of the
phenotype in multifactorial diseases.2,3 Indeed, our work has shown that metabolomics can address these current
unmet needs4 in AMD. We developed a prospective study including patients with AMD and controls that were
followed over 5 years (R01EY030088). We identified changes in the metabolomic profile of patients with AMD
compared to controls, differences across AMD severity stages5 mostly in specific lipid and amino acid pathways,6
as well as changes related to AMD progression.5,7 Additionally, we identified strong associations between
glycerophospholipids and specific AMD single nucleotide polymorphisms (SNPs).8,9 The current application is of
the natural progression of our R01EY030088 research. We aim to further characterize the disease-causing
mechanisms of AMD by quantifying previously identified metabolomic signals using targeted metabolomics.
Direct quantification is crucial to confirm that these pathways are indeed dysregulated in AMD. To do so, we will
validate the AMD associated metabolites and determine AMD risk by performing targeted metabolomic assays
to: (Aim 1A) compare plasma metabolite quantifications between patients with AMD and controls, and across
stages of disease; (Aim 1B) characterize the metabolome of eyes with AMD on retinal tissues samples from in
donor eyes with AMD and controls; (Aim 1C) develop and create novel polymetabolomic risk scores for AMD
and explore plasma-tissue metabolic correlations. Additionally, we will (Aim 2) characterize the metabolome of
AMD progression longitudinally by comparing the profiles of AMD-progressors versus non progressors at 5-
years; and (Aim 3) identify key mechanistic pathways and endotypes of AMD using multiomics: In particular,
(Aim 3A); we will characterize metabolite-genetic correlations of AMD and its progression and (Aim 3B) use
machine learning to identify endotypes of AMD to better classify the phenotypic diversity of the disease and point
to potential treatment targets. By using plasma and tissue targeted metabolomics and studying metabolomics-
gene interactions, in this proposal, we will increase the current understanding of the mechanisms that cause
AMD and identify possible new targets for prevention and earlier intervention. The experiments outlined in this
proposal represent the essential next phase to identify biological biomarkers of AMD and AMD progression,
contributing to improved screening and risk assessment and ushering in an era of precision medicine for this
blinding condition.

Public health relevance
PROJECT NARRATIVE The underlying causes of age-related macular degeneration (AMD) development and progression are unclear— there are no treatments for early and intermediate AMD or ways to halt disease progression; thus, AMD remains a leading cause of blindness worldwide. Our previous R01 work has shown that untargeted metabolomics (semi-quantitative study of small molecules that reflect both genetic and environmental exposures) is an effective way to identify plasma profiles of AMD patients, and that lipids (glycerophospholipid, fatty acids and bile acids) and amino acids (alanine, aspartate, glutamate and taurine and hypotaurine) pathways are driving these changes. In this proposal, we aim to expand on our previous work by using targeted metabolomics to quantify key metabolites and examine their relation to genetic profiles, allowing us to: (i) provide unique insights into the mechanisms of AMD; (ii) create the basis to establish biomarkers for AMD diagnosis and progression, and to assess individual disease risk; (iii) identify disease subtypes based on metabolomics and genomics; and (iv) accelerate the development of novel targets for earlier treatment and prevention of progression to the blinding stages of this condition.